Molecular Basis of Multidrug Binding and Transport by the MATE Transporters

DESCRIPTION (provided by applicant): Multidrug and Toxin Extrusion (MATE) transporters are integral membrane proteins that move structurally unrelated lipophilic cations across the cell membrane by utilizing a preexisting sodium or proton gradient. Bacterial MATE transporters function as multidrug efflux pumps by expelling a cohort of antimicrobial agents from the cytoplasm, whereas their human counterparts mediate the excretion of various cytotoxic metabolites as well as therapeutic drugs. Given their functional relevance to the unwanted resistance to antimicrobials and chemotherapy, molecular structures of the MATE transporters will reveal not only how they transport their substrates across the cell membrane but also how their transport activity can be modulated in order to overcome drug resistance. We aim to elucidate the molecular structure of an intact MATE transporter using X-ray crystallography. To date we have obtained crystals that diffract better than 3.8 E-resolution. Based on the crystal structure, we will construct various MATE mutants, reconstitute them into liposomes and characterize their transport properties utilizing substrate uptake assays. Our long-term objective is to decipher the molecular basis for multidrug binding and transport. Specifically, we seek to (1) establish the structures of a MATE transporter with and without drug substrates; (2) probe the transport mechanism via functional reconstitution of purified MATE transporters in liposomes; (3) determine the structures and drug-binding specificities of various MATE mutants. Our work will provide new insights into the general principles that govern multidrug binding and transport; it will also set the stage for structure-based design of pharmaceuticals targeting drug-resistant human pathogens and cancer cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: Multidrug resistance is a widespread and serious health issue. The proposed studies seek a deep understanding of multidrug transport, a key and evolutionarily conserved mechanism that underlies multidrug resistance. The proposed research has relevance to public health, because the findings are generally applicable to combating both drug- resistant pathogenic microorganisms as well as human cancer cells. Multidrug resistance is a widespread and serious health issue. The proposed studies seek a deep understanding of multidrug transport, a key and evolutionarily conserved mechanism that underlies multidrug resistance. The proposed research has relevance to public health, because the findings are generally applicable to combating both drug- resistant pathogenic microorganisms as well as human cancer cells. __SpecificAimsTextDelimiter__ Specific Aims Multidrug resistance poses a serious healthcare problem in the battle against both pathogenic microorganisms and human cancers (1-2). One ubiquitous family of membrane transport proteins responsible for multidrug resistance is the MATE (Multidrug and Toxin Extrusion) transporter family (3). MATE proteins can transport a broad range of structurally unrelated organic compounds across the cell membrane, which include antibacterial, antifungal and perhaps anticancer drugs (4). The MATE-mediated transport process is coupled with the discharge of the transmembrane sodium or proton gradient, but the mechanistic details of this transport process are largely unknown. The long-term goal of our research is to gain a chemical understanding of the molecular mechanism by which MATE proteins recognize and transport their drug substrates. We propose to use X-ray crystallography to reveal the molecular structures of MATE transporters captured at different conformational states and to employ functional reconstitution of the engineered MATE variants to probe the transport mechanism. Functional reconstitution will be conducted in close collaboration with Dr. Ronald Kaplan, a collaborator on this application, who has extensive experiences in characterizing the functions of Na+- coupled citrate transporters in vitro. Altogether, our study will pave the way for the structure-based design of pharmaceuticals to target both drug-resistant pathogens and cancer cells; it will also shed light on the molecular mechanisms of multidrug binding and transport. Overall, we propose to examine the following hypotheses: (a) During transport, a MATE transporter alternates between the inward- and outward-facing conformations so that the drug-binding site can be accessible from the intracellular and extracellular sides of the membrane, respectively; (b) To achieve multidrug or "poly-specific" drug binding, the MATE transporter utilizes a large internal cavity in the transmembrane domain to accommodate structurally distinct lipophilic compounds, and employs membrane-embedded negatively charged residues to specifically select cationic drugs for transport. In brief, our proposed research will achieve two specific aims: Aim 1. Determine the molecular structures of an intact MATE transporter. (i) Establish the X-ray structure of a ligand-bound MATE transporter at 3.8 Å- resolution. (ii) Improve the diffraction limit to a resolution better than 3.0 angstroms. (iii) Solve the crystal structure of a ligand-free MATE transporter. (iv) Determine the structures of the transporter in complex with other organic substrates. Aim 2. Elucidate the molecular basis of multidrug transport and binding. (i) Examine the dependence of drug transport upon sodium or proton gradients via functional reconstitution of the purified transporters in liposomes. (ii) Identify the substrate translocation pathway using site-directed mutagenesis and functional assays. (iii) Mutate drug-binding amino acid residues in the MATE transporter and examine the substrate binding specificities of these variants. (iv) Establish the X-ray structures of MATE variants with altered transport properties.